Patient-facing decision support for HIV and sexually transmitted infection prevention in low-income and minority patient populations.

Project Summary: The overarching goal of this project is to provide Dr. Jackman with a rich training program
that adequately prepares him to become an independent investigator focused on the development and
implementation of digital healthcare interventions to address health disparities among minoritized populations.
The United States has experienced record-breaking highs in sexually transmitted infection (STI) incidence and
persistent disparities in STIs and human immunodeficiency virus (HIV) infections and sequelae among
adolescent and young adult (AYA), low income, and Black/African-American populations. Serious adverse
health consequences are attributable to STIs, including pelvic inflammatory disease, ectopic pregnancy,
congenital syphilis, HIV, and infertility in an estimated 20,000 U.S. women annually. Patient centered clinical
decision support (PC CDS) are personalized, patient-centric, patient-facing digital healthcare applications used
to deliver patient care between health visits. This proposed program will leverage the electronic health record
(EHR) patient portal in a novel PC CDS intervention to optimize sexual health decision making, partner
communication, and uptake of clinical services among AYA aged 15 to 25 years in Baltimore, MD. Preliminary
studies demonstrate the promise of EHR patient portal-based interventions to help youth overcome barriers
such as, limited STI/HIV testing and treatment access, the stigma that often leads to non-disclosure, disclosure
inaccuracies, and access to high quality and accurate STI/HIV-related information and resources. Recently,
language included in the 21st Century Cures Act Final Rule, National HIV/AIDS Strategy, and STI National
Strategic Plan bolsters patient portals as a critical tool for improving patient healthcare engagement. However,
as reliance on patient portals and telehealth services have increased since the COVID-19 pandemic, so does
the risk of perpetuating inequities in healthcare access among socioeconomically underserved youth. Yet,
there is a considerable lack of interventions designed using a paradigm that amplifies the unique voices and
experiences of minoritized AYA end-users to meet their healthcare engagement needs and preferences for
STI/HIV prevention through the patient portal. This mentored research career development award is designed
to provide the necessary training to excel in digital healthcare research focused on reducing health disparities
and contribute to the public health informatics sciences. Research aims are to: (a) Describe longitudinal
patterns and correlates of EHR patient portal use among urban AYA patients in a large academic health
system; (b) Use a design thinking process to develop a PC CDS intervention to support the uptake of STI/HIV
prevention services and behaviors among urban AYA patients via the EHR patient portal, and (c) Conduct a 3-
month pilot study to determine feasibility and acceptability of the intervention. This study will provide crucial
preliminary data to inform the design of an R01-funded randomized trial to determine the effectiveness of a
novel PC CDS intervention to optimize patient portal engagement and reduce STI/HIV risk among urban AYA.

Public health relevance
Project Narrative Urban adolescents and young adults (AYA) face formidable barriers to making healthy decisions core to sexually transmitted infection (STI) prevention, such as, communicating with sex partners and health providers about STI testing, including for the human immunodeficiency virus (HIV), connecting to scientifically accurate STI/HIV informational resources that are culturally and linguistically appropriate, and utilizing the clinical services available to prevent new infections. Using a design thinking framework, we will a) Characterize AYA's use of electronic health record (EHR) patient portals and determine the correlates and patterns of longitudinal use; b) Develop a patient-centered clinical decision support intervention that leverages the EHR patient portal system to optimize patient engagement in STI/HIV prevention behaviors among urban AYA, and c) Pilot test the intervention among urban adolescents residing in an STI/HIV prevalent community. Successful completion of the mentored award will provide the requisite training to become an independent investigator with expertise in developing and evaluating digital healthcare strategies that reduce health disparities associated with STIs/HIV, give voice to a hitherto low-resourced and minoritized population, and move the United States population towards the Healthy People 2030 Goals.